Modulating Fibro/Adipogenic Precursors to Prevent Adipogenic Replacement of Muscle

ABSTRACT.
Successful muscle regeneration requires an elaborate cellular choreography between multiple
cell populations to remove and replace damaged fibers. Disruption of this choreography leads to
muscle degeneration and fibrotic or adipogenic replacement of myofibers. This phenomenon is
particularly prevalent in muscular dystrophies, where progressive muscle loss leads to severe
debilitation and early loss of life. Hence, there is growing need to understand the cell
populations and their interactions which contribute to myofiber regeneration, but can lead to
fibrotic or adipogenic replacement when gone awry. This project aims to understand the
mechanism underlying impaired cellular interactions leading to myofiber loss and muscle
weakness in limb girdle muscular dystrophy type 2B and test approaches to prevent this
impairment. This understanding will help develop novel targeted therapeutic approaches to
arrest disease progression in this and other muscular dystrophies that are currently without
effective treatment options.

Public health relevance
PROJECT NARRATIVE. This work aims to identify and target the mechanisms which cause the replacement of muscle fibers with fatty tissue after injury. Such an advance will have major implications for muscular dystrophy and other degenerative diseases where fatty replacement of muscle fibers leads to progressive and debilitating muscle weakness.